2023 International HBV Meeting

ABSTRACT/SUMMARY
Hepatitis B virus (HBV) is a major global public health threat with approximately 296 million chronically
infected people worldwide and over 800,000 deaths per year. Chronic HBV infection is a leading cause for
development of liver cirrhosis and hepatocellular carcinoma. Despite the effectiveness of the prophylactic HBV
vaccine, it has no impact on established chronic infections. Consequently, there is a great need to discover new
therapeutic strategies to cure chronic HBV infection and slow or stop the resulting disease.
The annual International HBV Meeting is the only forum that gathers the international community of
researchers who study infection, persistence, pathogenesis, and drug development for HBV and the closely
associated hepatitis delta virus (HDV). This International HBV Meeting has been held yearly since 1985. In 2023,
this meeting will be held for the first time in Japan, in East Asia where chronic hepatitis B is highly endemic, with
over 100 million people chronically affected.
Success of the International HBV Meeting relies on the contributions of not only the established
investigators, but importantly, also on early career researchers from diverse backgrounds. To facilitate the
participation of young scientists, we request funding to support travel expenses for early career and under-
represented researchers at the 2023 International HBV Meeting. This 2023 meeting will provide the
opportunity for scientific exchange and dissemination of the latest research information to discover new
strategies for potentially curing HBV and HDV. An estimated 500-600 delegates will attend the 2023 meeting.
The meeting will consist of 10 oral scientific sessions, 2 poster sessions, 3 plenary lectures from experts outside
of the HBV field who will bring different perspectives, and a lecture given by the recipient of the Distinguished
Award in HBV Research that is awarded annually by the meeting. Toward the goal of curing HBV and HDV, this
meeting will be satellited by HBV cure symposium to discuss mechanisms underlying durability of anti-HBV
siRNA therapy, and by an HBV community forum where scientists from the HBV community engage with the
general public, media, students and those affected by HBV to discuss HBV/HDV and the related diseases.
As in the past, great effort has been made to minimize the cost of the meeting. A major strength of the
meeting organization being continual support from the Hepatitis B Foundation since 2005. In order to enable and
facilitate participation of early career researchers and under-represented minority investigators to maximize the
significance of the meeting, we request support from the National Institutes of Health to help defray their travel
costs. This funding will be used to ensure attendance and presentation by early career researchers, particularly
from low and middle-income countries, as well as disadvantaged and under-represented minority investigators.

Public health relevance
Project Narrative Hepatitis B virus (HBV) chronically infects 290 million people world-wide and causes liver cancer and liver failure for which there are no curative treatments, so there is an urgent need to develop better antiviral therapies. The International HBV Meeting is the only meeting that brings together scientists studying HBV and its satellite hepatitis delta virus (HDV) to present and discuss the newest fundamental discoveries of HBV and HDV biology that have the potential to evolve into new antiviral approaches for curing HBV and HDV infections, thereby preventing the development of the associated liver diseases. This application seeks funding for travel grants to support attendance of early-stage investigators and under-represented scientists at the HBV meeting to maximize diversity of attendees and the variety of ideas and opinions that they bring with them.